Subjective Symptoms after Treatment of Lyme Disease

DESCRIPTION (provided by applicant): Symptoms Lyme disease is the most common tick-borne infection in North America. Although the outcome after treatment is generally excellent, some patients complain of persistent subjective symptoms such as fatigue, musculoskeletal pains, or problems with concentration and memory despite resolution of the objective signs of the disease. However, these symptoms are also common in the general population and a causal association between Lyme disease and persistent symptoms has not been established. An unanswered and critically important question is whether, after treatment for Lyme disease, patients are more likely to have chronic (>6 months) subjective symptoms than are individuals who did not have Lyme disease. To answer this fundamental question, we propose to conduct the first prospective, controlled longitudinal cohort study in the United States in which subjects with and without Lyme disease are carefully evaluated in a similar manner for a full year. This study will also be the first to be able to determine the incidence of post-Lyme disease syndrome (PLDS) and the associated medical complications and economic costs. We will also obtain a blood sample from such patients to be shared with other investigators for future research on possible biomarkers associated with PLDS. Finally, in a different cohort of patients, we will describe for the first time the outcome of culture-confirmed patients with early Lyme disease more than 10 years after diagnosis and treatment.

Public health relevance
PUBLIC HEALTH RELEVANCE: The purpose of our study is to determine whether patients treated for Lyme disease are more likely to have persistent symptoms than individuals who did not have Lyme disease. To answer this fundamental and previously unanswered question, we propose to conduct the first prospective study in the United States in which subjects with and without Lyme disease are carefully evaluated in a similar manner for a full year. In a different group of patients, we will describe for the first time the outcome of patients with early Lyme disease more than 10 years after diagnosis and treatment. Subjective Symptoms after Treatment of Lyme Disease The purpose of our study is to determine whether patients treated for Lyme disease are more likely to have persistent symptoms than individuals who did not have Lyme disease. To answer this fundamental and previously unanswered question, we propose to conduct the first prospective study in the United States in which subjects with and without Lyme disease are carefully evaluated in a similar manner for a full year. In a different group of patients, we will describe for the first time the outcome of patients with early Lyme disease more than 10 years after diagnosis and treatment. __SpecificAimsTextDelimiter__ Specific Aims Lyme disease is a tick-borne zoonotic infection caused by Borrelia burgdorferi sensu lato. The most common clinical manifestation is a characteristic skin lesion called erythema migrans. Extracutaneous manifestations may involve the joints, nervous system, or heart. Although the outcome of treatment is generally excellent, when questioned at >6 months after treatment some patients with Lyme disease report purely subjective symptoms such as fatigue, musculoskeletal pains, or concentration and memory difficulties. These symptoms, however, are non-specific and also regularly occur in the general population. Whether etiologically related to the borrelial infection or not, it is clear that for some patients these symptoms may last for at least 6 months and cause functional disability, thus potentially fulfilling the criteria for what has been termed post-Lyme disease syndrome (PLDS). In eight randomized treatment trials of patients from the United States with erythema migrans, the frequency of post-Lyme disease symptoms at >6 months after antibiotic treatment has ranged from none to 40.8%(median 11.5%). However, since none of these studies included a control group evaluated in the same manner contemporaneously, it is impossible to conclude from them that either the frequency or severity of such symptoms following Lyme disease exceeds that of similar symptoms found in the general population. In fact, no study designed to address this specific and critically important question has ever been conducted in the United States. Specific aim 1 is to compare in a prospective cohort study during a 12 month follow-up interval the frequency and severity of subjective symptoms following antibiotic treatment in Lyme disease patients with erythema migrans, with the frequency and severity of these symptoms in controls of similar age, gender and race. In addition, we will determine the frequency of PLDS in this patient cohort. Specific aim 2 is to address whether there are identifiable factors at the time of diagnosis of Lyme disease that would predict those patients more likely to have persistence of symptoms or PLDS. This question will be addressed in the prospective cohort study described above, as well as in a larger cohort of adults with culture-confirmed erythema migrans who by the summer of 2011 (the first summer encompassed within the grant period) will have been prospectively followed at New York Medical College for up to 11-20 years after treatment. In addition, evaluation of this second cohort will enable us to assess the very long-term outcome of patients with early Lyme disease following antibiotic treatment. Specific aim 3 is to bank blood from patients with persistent symptoms for future research by qualified investigators on potential biomarkers. Specific aim 4 is to quantify the medical complications and economic burden associated with PLDS.